The function of MS4A3 in normal and malignant hematopoiesis

Chronic myeloid leukemia (CML) is caused by BCR-ABL1, a constitutively active tyrosine kinase generated from
the Philadelphia chromosome. In the chronic phase of CML (CP-CML), myeloid cells are expanded, but maintain
terminal differentiation. Most CP-CML patients achieve durable responses to BCR-ABL1 tyrosine kinase
inhibitors (TKIs), and their extended survival is reflected by a steep rise in CML prevalence. Unfortunately, TKIs
fail to eliminate quiescent CML stem cells (LSCs) whose survival is independent of BCR-ABL1, necessitating
lifelong TKI therapy to prevent CML recurrence. In 5-10% of patients, a differentiation block converts CP-CML
into blast phase CML (BP-CML), an aggressive acute leukemia that is often BCR-ABL1-independent and TKI
resistant. Our overarching hypothesis is that blocked differentiation is central to the BCR-ABL1 independence
that characterizes the extremes of the clinical CML spectrum: Persistence of residual leukemia despite TKI
therapy and TKI-resistant BP-CML. We have discovered that expression of MS4A3, a member of the MS4A
(membrane-spanning four A) family of signaling proteins, is profoundly reduced in quiescent, TKI resistant and
BP CML cells, and that low MS4A3 correlates with shorter survival. MS4A3 knockdown (KD) in CML CD34+ cells
inhibits myeloid differentiation, and promotes TKI resistance, while ectopic MS4A3 expression has opposite
effects (Zhao et al. Blood. 2021;Epub ahead of print. PMID: 34780648). Our preliminary data suggest that MS4A3
promotes IL-3 and GM-CSF signaling in CML CD34+ cells by promoting endocytosis of their cognate β common
chain (βc) receptors. We hypothesize that MS4A3 promotes myeloid differentiation by enhancing response to βc
cytokines in leukemic stem and progenitor cells (LSPCs). TKI resistant CML cells downregulate MS4A3 to blunt
response to differentiation-inducing cytokines, thereby maintaining a primitive, therapy-resistant state. Re-
establishment of MS4A3 expression will enforce differentiation and enhance drug sensitivity. In Aim 1, we will
delineate how MS4A3 regulates endocytosis and signaling of βc cytokine receptors. We will track endocytosis
by high-throughput immunofluorescent and confocal live cell imaging, identify MS4A3 cofactors by mass
spectrometry, and MS4A3-regulated signaling pathways by reverse phase protein array. In Aim 2, we will
determine the function of MS4A3 in normal hematopoiesis. We will generate mouse strains with hematopoietic-
specific conditional Ms4a3 knockout or inducible overexpression and characterize their hematopoietic system at
steady state and under stress. In Aim 3, we will delineate the role of MS4A3 in CML hematopoiesis and as a
therapeutic agent in CML. We will test whether modulating MS4A3 expression in LSPCs affects leukemogenesis
and TKI response, and whether MS4A3-loaded nanoparticles attenuate BP-CML in xenografts. If successful, we
will establish MS4A3 as a novel master regulator of βc cytokine signaling that governs signal strength by
modulating endocytosis. BP-CML remains mostly incurable, and most CP-CML patients require lifelong TKI
therapy. Our work may provide proof of concept for using forced MS4A3 expression to overcome TKI resistance.

Public health relevance
PROJECT NARRATIVE Most patients with chronic myeloid leukemia (CML) require life-long therapy with BCR-ABL1 tyrosine kinase inhibitors (TKIs) to avoid relapse. CML cells minimize expression of membrane-spanning four A (MS4A3) to escape TKIs. We will identify the underlying mechanism, and whether re-expression of MS4A3 can be harnessed to increase response to TKIs.